Role of Soluble Guanylate Cyclase Alpha 1 in Open Angle Glaucoma

DESCRIPTION (provided by applicant): Open angle glaucoma (OAG) is a prevalent disease that results in irreversible loss of vision through the death of retinal ganglion cells (RGCs). Although several risk factors for OAG have been identified, including elevated intraocular pressure (IOP), the exact molecular mechanisms leading to OAG remain poorly understood. It remains to be determined how systemic blood pressure (BP) and gender contribute to OAG. Finally, available therapies delay disease progression but offer incomplete protection, and development of new therapeutic strategies has been hampered by the lack of animal models of OAG. Our preliminary data establish mice deficient in the nitric oxide (NO) receptor soluble guanylate cyclase α1 (sGCα?1 -/-) as a new animal model for OAG, and identify sGCα?1 -/- mice as a unique model to study the relation between blood pressure, gender, and OAG. Furthermore, this new animal model of moderately increased IOP and OAG represents an important tool to teststrategies for disease prevention and treatment of elevated IOP and OAG. We hypothesize that sGCα?1 -deficiency predisposes RGCs to modest IOP increases in a gender-specific manner. Our hypothesis will be tested in three specific aims. Aim 1 - Determine the role of gender and BP in the development of OAG in sGCα?1 -/- mice. Objective A - Determine whether male sGCα?1 -/- mice develop OAG. Objective B - Test whether sex-hormones affect the development of OAG in sGCα?1 -/- mice. Objective C - Investigate whether BP modulates OAG risk in sGCα?1 -/- mice. Aim 2 - Test whether sGCα?1 -deficiency predisposes to optic neuropathy associated with elevated IOP. Objective A - Study the effect of increasing IOP (with microbeads) on the retinal nerve fiber layer (RNFL) and the optic nerve (ON) in young WT and sGCα?1 -/- mice. Objective B - Assess retinal and ON damage in mice in which sGCα?1 is selectively deficient in RGCs. Aim 3 - Investigate the ability of available compounds that enhance cGMP signaling to prevent optic neuropathy in OAG associated with sGCα?1 -deficiency. Objective - Serially measure the impact of treating sGCα?1 -/- mice with the cGMP-elevating compounds sildenafil (a phosphodiesterase (PDE) 5-antagonist), brain natriuretic peptide (BNP, a peptide activator of membrane bound guanylate cyclase (pGC)), and cinaciguat (an sGC-activator) on AqH outflow, IOP, RNFL thickness, and ON axon count. We anticipate that the studies described in this proposal will further our knowledge of the etiology o OAG by elucidating the role of impaired NO-cGMP signaling, gender, and BP in the development of OAG. We furthermore expect to identify cGMP signaling as a promising therapeutic target in the treatment of OAG.

Public health relevance
Our preliminary data identify mice deficient in the α1 subunit of soluble guanylate cyclase (sGCα?1 -/- mice) as a novel and unique model of open angle glaucoma (OAG). This research project aims to i) elucidate the role of impaired NO-cGMP signaling, gender, and ocular perfusion pressure in the development of OAG, ii) further our knowledge of the etiology of OAG, focusing on the susceptibility of retinal ganglion cells to changes in IOP, and iii) identify cGMP signaling as a therapeutic target in the treatment of OAG.